Advancing health equity in preeclampsia prevention

PROJECT SUMMARY
The higher incidence of preeclampsia in Black compared to White pregnant populations is one of the leading
contributors to racial disparities in maternal morbidity and mortality. Due to the higher preeclampsia rate in
Black populations, the U.S. Preventive Services Task Force, American College of Obstetricians and
Gynecologists, and Society for Maternal-Fetal Medicine endorse a decision algorithm that includes patient race
to guide the use of low-dose aspirin to prevent preeclampsia. In this algorithm, Black patients need fewer
preeclampsia risk factors than do patients of other races before aspirin is recommended for prevention. Black
race was included in the algorithm because of a large epidemiologic literature demonstrating disparities in both
preeclampsia and preeclampsia-related morbidity and mortality between Black and White pregnant
populations. However, preeclampsia research has focused almost exclusively on Black-White disparities, with
little research examining rates in other racial groups. Our preliminary research suggests that the current low-
dose aspirin algorithm is missing multiple racial groups who have high rates of preeclampsia but who are
underrepresented in the scientific literature. Without the inclusion of all racial groups with high rates of
preeclampsia, the current low-dose aspirin therapy algorithm cannot be equitably applied to all pregnant
people to reduce preeclampsia disparities. The objectives of the proposed research are thus to identify the
understudied minoritized racial and ethnic groups who experience disparities in preeclampsia and to model the
potential to prevent preeclampsia if they were included in the low-dose aspirin decision algorithm. In Aim 1, we
will use hospital discharge data from the Healthcare Cost and Utilization Project’s State Inpatient Databases to
estimate preeclampsia rates in diverse racial groups and identify those with high rates of preeclampsia. In Aim
2, we will use Markov state-transition models to compare 4 strategies for modifying the low-dose aspirin
algorithm to be inclusive of more racial groups and will determine which of these strategies can best prevent
preeclampsia and reduce racial disparities: (1) no change to the algorithm, (2) adding new racial groups with
high rates of preeclampsia, (3) removing race from the algorithm, and (4) recommending aspirin to all pregnant
patients. The long-term goal of this research is to ensure that all patients have equitable access to low-dose
aspirin, one of few evidence-based therapies shown to prevent preeclampsia. By modifying a clinical algorithm
used nationwide, this research will have important impacts on reducing disparities in preeclampsia and
associated maternal morbidity and mortality in the United States.

Public health relevance
PROJECT NARRATIVE Research on racial disparities in preeclampsia has focused almost exclusively on Black-White disparities, with little research examining preeclampsia rates in other racial groups. The proposed research will identify understudied minoritized racial groups with high preeclampsia rates and will model the potential to prevent preeclampsia if these groups were included in an existing race-based clinical guideline for the use of low-dose aspirin to prevent preeclampsia. The long-term goal of this research is to ensure that all patients have equitable access to low-dose aspirin, one of few evidence-based therapies shown to prevent preeclampsia.